Interdisciplinary Immunology Training Program

PROJECT SUMMARY The goal of the Yale Interdisciplinary Immunology Training Program (YIITP) is to equip predoctoral and postdoctoral trainees with the intellectual and research foundations necessary to become independent scientists/educators investigating the immune system and its roles in human disease. The YIITP combines rigorous research training in a highly collaborative, interactive environment with a thorough academic program of instruction in immunology and related disciplines. The program offers training in virtually all aspects of immunology as well as host-pathogen interactions and a variety of autoimmune and inflammatory disorders. Areas of particular strength include innate immune recognition and function, cancer immunology, immunological tolerance and memory, microbiome-immune system interactions, metabolism and immunity, antigen presentation, immune cell signaling, the immune response to infectious organisms, and autoimmune diseases such as Type 1 diabetes, multiple sclerosis, and systemic lupus erythematosus. The 30 YIITP mentors have an outstanding record of research accomplishment and training and many are leaders in their fields. The YIITP is overseen by the Program Director, David Schatz, and an Executive Committee of four additional faculty members. The principal training entity is the Department of Immunobiology, whose graduate program was the top ranked immunology graduate program in the United States in a 2010 National Research Council study. All students admitted to the YIITP have at least a Bachelor's degree in a relevant field and enter via application to the Yale interdepartmental program in Biological and Biomedical Sciences (BBS). Postdocs enter from the labs of YIITP faculty, and hold a Ph.D. and/or M.D. degree. Predoctoral training leading to the Ph.D. degree involves formal course work in Immunology and other areas of biology, research rotations, teaching, and the qualifying exam in the first two years, with dissertation research beginning late in year one and becoming the primary focus of activity after completion of the qualifying exam. Postdoctoral training focuses on research in the laboratory of one or more of the mentors and incorporates an array of skill and career development courses and activities. Both predoctoral and postdoctoral training are enriched by intensive training in the methods, logic, and responsible conduct of research, and by the many opportunities for collaboration and interaction. The vast majority of YIITP trainees go on obtain independent research and teaching positions at academic institutions or research positions in biotechnology companies. Extensive efforts are made by YIITP mentors and Yale Graduate and Medical Schools to attract and retain trainees from diverse backgrounds, particularly under-represented minority groups. This proposal requests support for 10 predoctoral and 3 postdoctoral trainees who will be supported by this grant for 2 years. Graduate students are supported during years 2 and 3 of training while postdocs are supported for up to two years beginning in their first or second year of postdoctoral training.

Public health relevance
PROJECT NARRATIVE The Interdisciplinary Immunology Training Program at Yale University supports the education and training of the next generation of scientists who will study the immune system, the system of the body responsible for combating infectious diseases. Graduates from this program go on to leading positions in universities and industry, where they contribute to finding new vaccines, new therapies to combat viruses and bacteria, and new treatments for cancer and autoimmune diseases such as diabetes, lupus, and rheumatoid arthritis and hypersensitivity disorders such as asthma.